Use and outcomes of anticoagulants for the treatment and prevention of thrombosis among hospitalized patients

Project Summary/Abstract
Anticoagulants are used for indications ranging from stroke prevention in atrial fibrillation to the acute treatment
of venous thromboembolism. However, anticoagulants are also associated with significant risks of bleeding, as
well as costs and burden to patients. Despite the morbidity and mortality associated with cerebrovascular
diseases and stroke, many people do not receive antithrombotic therapy, and many people at high embolism
risk are not anticoagulated. Dementia and cognitive decline are commonly cited as deterrents to anticoagulant
use. This administrative supplement has two major goals (1) to create research infrastructure to support junior
investigators studying the intersection between thrombosis, anticoagulant medications, and dementia; and (2)
to expand Dr. Margaret Fang's research program in thrombosis to examine the association between atrial
fibrillation, antithrombotic medications, and cognition. Funding from this supplement will be used to refine and
characterize dementia outcomes in a sub-cohort of people with atrial fibrillation in the longitudinal Health and
Retirement Study.
Dr. Fang is a hospitalist and the Research Director of the University of California, San Francisco (UCSF)
Division of Hospital Medicine. Her research program is based in the outstanding clinical, training, and research
environment of UCSF and connects investigators in hospital medicine, hematology, geriatrics, and
pharmacology.

Public health relevance
Project Narrative This proposal will describe the association between atrial fibrillation and incident cognitive impairment and dementia in a nationally-representative study of older adults in the United States. This supplement will also support the research infrastructure and mentorship of early career investigators studying thrombosis, bleeding, and outcomes of antithrombotic therapies.